Wearable Metabolic Sensor for Monitoring of Lactate and Glucose for People with Diabetes

Wearable Metabolic Sensor for Monitoring of Lactate and Glucose for People with
Diabetes
ABSTRACT
Diabetes technology has made enormous progress over the last decade with the advent of
Automated Insulin Delivery (AID) systems and Continuous Glucose Monitoring (CGM) systems,
bringing sophisticated computerized management systems to the continuous delivery of insulin.
However, due to limited contextual information on the external influences to glucose, nutrition
ingestion and exercise, the systems have increased the level of user burden with requirements to
manually enter this guidance into the AID. Missing entries could result in unintended
consequences, such as hypoglycemia due to missing an exercise input and hyperglycemia due
to missing a nutrition input. A continuous sensor that measures exercise through an
accelerometer and lactate production as well as glucose could minimize both hypoglycemia and
user burden and achieve better time in target range. The Phase I and Phase II funding from
NIDDK has helped us establish benchtop feasibility of the technology and a self-funded First in
Human clinical research study has shown promise to further progress toward broader clinical
research studies and verifying of commercial potential. This Phase IIb submission requests
funding for final technology optimization, pilot process, confirming final regulatory requirements
with the FDA, and initial commercial planning activities.

Public health relevance
PROJECT NARRATIVE The proposed project aims to develop a microneedle array-based biosensor for the continuous assessment of both glucose and lactate levels in the dermal interstitial fluid. This new multi-variate biosensor paradigm will impart the ability to perform low-latency metabolic sensing, providing insight into glucose levels in context to exercise-modulated lactate levels, that without monitoring can result in instances of hypoglycemia. The development activity proposed will, in the future, lead to the validation, pivotal clinical testing, and eventual commercialization of a unique wearable multi-variate sensing platform to reduced patient burden, which will augment the safety and effectiveness of Diabetes therapy and in the future can integrate into open and closed loop hormone replacement systems.